Mayo Clinic Research Education Program in Computational Autonomic Neurobiology of Diabetes and Digestive and Kidney Diseases

Project Summary / Abstract
Modern biomedical science and medicine, with large varied and complex datasets, requires a
paradigm shift in our educational models to train the next generation of scientists and physicians
capable of performing and interpreting computational analyses. Current educational models have
created a critical gap of expertise between computational data scientists and disease-oriented
physiologists. The Specific Aim of this proposal is to establish an innovative educational model to
promote the training of computational skills for immediate and direct application to research
experiences and create the next generation of biomedical scientists to lead new discoveries in
diabetes, digestive and kidney disease-oriented research. The Mayo Clinic Research Education
Program in Computational Autonomic Neurobiology is a unique new program designed to ensure
foundational understanding of both computational science and disease-oriented physiology, prior to
learning practical skills in computational methods that are directly applied to data from mentored
research experiences. Participants in the program, including graduate students, post-doctoral fellows,
biomedical engineers, medical residents, and clinical fellows, are recruited widely from existing
educational, training and research programs via the international reputations and productivity of the
highly invested participating faculty. The program leverages institutional resources for program
administration and robust program evaluation to remain adaptive and responsive to the needs of
participants. The short-term objectives of the program are to: 1) provide foundational knowledge in
physiology and computational science; 2) provide practical skill in the use creation and dissemination
of computational workflows; and 3) provide a research environment to enrich skill honing and
productivity. The long-term objectives of the program are to: 4) expand the use and access of
computational analyses to impact diabetes, digestive and kidney disease-oriented research; and 5)
attract and retain diverse scientists that impact the fields of diabetes, digestive and kidney disease-
oriented research. By completing the program, we anticipate these scientists will form a bridge
between the often distant physiological and computational approaches to understand human health
and form a generation of diverse scientists that impact the fields of diabetes, digestive and kidney
diseases.

Public health relevance
Project Narrative The Research Educational Program in Computational Autonomic Neurobiology is being developed at the Mayo Clinic in Rochester Minnesota to train a new generation of modern biomedical scientists and physicians capable of performing, interpreting, and applying analyses of increasingly complex and large datasets. By providing participants with foundational knowledge and practical skills to apply computer-based analyses to data from impactful research experiences, the program is poised to advance understanding of diabetes and digestive and kidney diseases.